Targeting Microglial Lipoprotein Lipase in Alzheimer's disease

ABSTRACT
Alzheimer’s disease (AD) is a devastating, age-associated, and ultimately fatal neurodegenerative disorder.
Although the prevalence of AD is increasing, there are no effective therapies that can prevent or delay AD onset.
Brain-derived lipoproteins (BLps) transport lipids throughout the brain and can protect against or
exacerbate AD progression, depending on their composition. For example, the E4 isoform of the major BLp
scaffold protein APOE can stabilize amyloid-beta (Aβ), leading to plaque formation and AD risk. However, due
to the suboptimal isolation of BLps in earlier studies, and the use of unlipidated APOE4, important questions
have been left unanswered. What factors regulate BLp processing, and can they be targeted to treat AD?
Microglia play a major role in BLp processing and AD pathophysiology. Recent studies have shown that
phagocytic microglia are defined by their elevated expression of lipoprotein lipase (LPL); the rate-limiting enzyme
in lipoprotein hydrolysis and uptake. Notably, LPL-expressing microglia engulf Aβ to protect against Aβ plaque
formation. The notion that LPL is protective is consistent with epidemiological studies showing reduced Aβ
plaque formation and decreased AD prevalence in individuals harboring gain-of-function LPL variants. Although
LPL is a potential target for the treatment of AD, this has not been validated in vivo.
My laboratory has substantial expertise in lipid metabolism, LPL biology, and microglia and is uniquely
positioned to investigate LPL as a therapeutic target for AD. We have previously shown that LPL regulates
microglial phagocytosis, lipoprotein uptake, and immune function, hence identifying LPL as an immunometabolic
gatekeeper in microglia. Furthermore, our compelling preliminary data has shown that increasing LPL activity
can enhance microglial phagocytosis of Aβ and BLps. Therefore, we hypothesize that microglial-LPL helps
to clear Aβ and excess BLps to protect against AD development and that increasing LPL activity in vivo
can ameliorate AD progression. To test this, in AIM I, we will use microglial-specific knockdown mice
(MiLPLKD) and AD-susceptible mice (5xFAD) to empirically determine whether pharmacological LPL activation
can halt AD progression. We will also use state-of-the-art metabolic imaging and ‘omics approaches to identify
LPL-dependent mechanisms controlling microglial metabolism and function. In AIM II, we will use native BLps
carefully isolated from human CSF to define LPL-dependent mechanisms governing lipoprotein processing by
microglia and to determine whether enhancing LPL activity is a rational strategy to restore lipid handling in
APOE4 carriers. The findings from this study will be transformative to our understanding of lipoprotein handling
in the brain and the mechanisms leading to AD neuropathogenesis. Our study will not only determine LPL-
dependent mechanisms regulating microglial metabolism and function but will also ascertain whether novel LPL
activators can improve microglial function to ameliorate AD pathology, a new strategy with major clinical impact.

Public health relevance
PROJECT NARRATIVE Lipoproteins are essential particles that transport fats to different cells in the brain. In individuals with Alzheimer's disease (AD), lipoproteins are not taken up by cells properly and instead bind to other factors outside the cell such as amyloid, leading to amyloid plaque formation, and damage to brain tissue and function. In this proposal, we aim to enhance the activity of the enzyme lipoprotein lipase (LPL), which can help specialized cells called microglia remove excess lipoproteins, prevent amyloid accumulation, and protect against the development of AD.